ACQUISITION OF THE YOKOGAWA CV8000 HIGH THROUGHPUT SPINNING DISK MICROSCOPE AND ROBOTICS

Project Summary/Abstract
In this application, the Integrated Microscopy Core (IMC) at Baylor College of Medicine (BCM, Houston, TX)
requests a Yokogawa Cell Voyager 8000 (CV8000) high throughput spinning disk confocal platform. The
CV8000 also is integrated with a hardware/software solution for a robotic plate-loader and incubated plate
hotel to allow 24/7 live imaging experiments. This type of platform is currently not available in the Houston
area, or anywhere in Texas. The IMC is a long-standing core facility supported in part by the NCI-funded Dan
L Duncan Comprehensive Cancer Center, the NIDDK-funded Texas Medical Center Digestive Disease Center
and the CPRIT-funded Gulf Coast Consortium Center for Advanced Microscopy and Image Informatics
(CAMII). In the last few years, there has been an increased need in the scientific community to query
biological processes at different scales of observation, both spatially (from single cells to organoids to model
organisms), and temporally (from seconds to days), and to translate findings into novel mechanisms of action
and therapeutic avenues. Because of increased capabilities in assay development and miniaturization (96-384
well plates), it is now possible to simultaneously query model systems under a large number of conditions (i.e.,
small molecule screening), and, through advanced image analytics, to quantify single object
phenotypic/mechanistic changes in multidimensional space (space, time, shape, texture, intensity) to create
highly complex, multiparametric views of pathophysiological phenomena.
The CV8000 provides us with the unique possibility of accomplishing the abovementioned tasks; it is a state-
of-the-art, industry standard, unmatched on the market, high throughput spinning disk confocal, with 6 laser
lines, 4 cameras, designed for low (4x) and high resolution (60x/water) imaging of live and fixed 2D/3D
samples. The included Cell Pathfinder high content image analysis software will complement currently
available bioinformatics resources available in the IMC/CAMII. The addition of the incubated robotic platform
and plate-loader by PAA will allow us to perform short- and long-term live imaging experiments without
continuous involvement of core personnel, or potential limitations from fixed-cell projects.
The versatility and ultra-high image quality of the CV8000 will provide many groups at BCM and the TMC with
results and experimental designs that are currently not possible or practical with available resources. As
detailed in the proposal, the CV8000 will serve groups that need multidimensional live/fixed imaging of
organoids, model organisms and other 2D/3D cell models. In partnership with CAMII and GCC Screening
Program and the Baylor Center for Drug Discovery, numerous small molecule libraries are available to support
a wide range of screening projects. The CV8000 will be a perfect addition to the battery of IMC resources and
will be integrated in our educational mission (seminars and graduate level microscopy class).

Public health relevance
Project Narrative The acquisition of the Yokogawa Cell Voyager 8000 (CV8000) high throughput/high content spinning disk confocal, together with the added incubator/robotic arm and integration PAA software, will be transformative for researchers that use the Integrated Microscopy Core at Baylor College of Medicine. The new resources will allow Core users, for the first time, to perform large (and small) screens with live imaging, complex 3D models and small molecule libraries. The proposed user group covers many translational areas, including cancer, gastrointestinal diseases, virology, environmental toxicology, neurodegenerative diseases and more.